ANALYSIS OF MCH DATA FROM THE NATIONAL LONGITUDINAL YOUTH SURVEY

This project has as its primary objective to analyze and publish data based on a series of annual interviews of young women (aged 14 to 21 on January 1, 1979) regarding their pregnancy outcome and the first year of life of the child. This survey allows analysis of trends over time in the maternal and child health field of, for example, the use of obstetric technology (diagnostic ultrasound, amniocentesis, etc.), and patterns in breast-feeding. In addition, a wealth of other data have been collected on the youth cohort sample in relation to their employment and work history, military service, educational attainments, etc. The collection of data on pregnancy outcome and the first year of life of the child began in 1983. The data tape for 1985 should be available for use by the end of calendar year 1986. With this three year data base, analysis of trends over time in the maternal and child health can be done. The Biometry Branch has joined in the funding of the data collection effort together with the Demographic and Behavioral Sciences Branch, Center for Population Research, NICHD. The mechanism of support for the field study is through an Inter Agency Agreement with the Department of Labor.